Innate Immunity to Spiral Ganglion Neuron Degeneration

PROJECT SUMMARY
Spiral ganglion neurons (SGNs), the primary afferent neurons in the cochlea, play vital functions in normal
hearing by transmitting auditory information from the mechanosensory hair cells to the brain, and in restoration
of hearing via cochlear implants in deaf individuals. However, exposure to traumatic and/or prolonged noise
causes degeneration and subsequent loss of SGNs and their synaptic connections with hair cells in varied
degrees, leading to degradation of auditory information, and impeding the performance of cochlear implants or
future hair cell or synapse regeneration strategies. The reasons for such SGN degeneration remain unclear. To
inform the development of novel therapies to preserve or regrow functional SGNs, it is critical to understand the
biological mechanisms of SGN degeneration and survival in the injured cochlea. We have recently identified
fractalkine signaling (CX3CL1-CX3CR1) between SGNs (which express chemokine CX3CL1 ligand) and innate-
immune cells such as macrophages and monocytes (which express cognate CX3CR1 receptor) as a key
neuroprotective signaling that promotes SGN survival and synapse repair in the injured cochlea. Here, we seek
to examine the cellular and molecular mechanisms by which fractalkine signaling mediates neuroprotection in
mouse cochleae following graded noise trauma. Specifically, Aim 1 will determine the precise roles of CX3CR1-
expressing cochlear resident and blood-derived recruited macrophages in SGN survival or degeneration after
noise trauma. Using fate mapping to distinguish and selectively deplete cochlear resident and recruited
macrophages, we will test the hypothesis that CX3CR1-expressing recruited macrophages promote SGN survival
after noise trauma. Aim 2 will determine whether CX3CR1 regulates macrophage responses after noise trauma
such that absence of CX3CR1 results in an increased and sustained production of pro-inflammatory cytokines
and reactive oxidative factors that is detrimental for SGN viability. Effector pro- and anti-inflammatory cytokines,
and reactive oxygen and nitrogen species will be detected in both cochleae and macrophages with intact
fractalkine signaling and those that lack CX3CR1 after noise trauma. Aim 3 will examine the relationship between
human CX3CR1 polymorphisms and noise-induced hearing loss. Approximately 25-30% humans carry two single
nucleotide polymorphisms (SNPs) in the CX3CR1 locus (hCX3CR1-I249/M280) that show defective binding to
CX3CL1 ligand and loss of chemotactic function in macrophages. Using a novel humanized mouse model
expressing the aforementioned human CX3CR1 SNPs, we will test the hypothesis that dysregulated macrophage
responses due to impaired CX3CR1 signaling in these variants accelerates synapse and neuron loss and
worsens hearing following noise trauma. Together, these studies will test fundamentally new hypotheses
proposing specific elements of the innate immune system, macrophages and fractalkine signaling as critical
targets for neuroprotective immunotherapies to promote synapse repair and SGN survival in an injured cochlea.

Public health relevance
PROJECT NARRATIVE Injury to the cochlea results in activation and infiltration of immune cells into the cochlea, where these cells play beneficial roles via fractalkine signaling in repairing damaged hair cell synapses and promoting long-term survival of spiral ganglion neurons (SGNs) that carry sound information to the brain. Our goal is to understand the mechanisms of fractalkine-mediated neuroprotection in the injured cochlea and to define the relationship between genetic mutations in human fractalkine signaling and noise-induced hearing loss. Knowledge gained from these studies will advance prevention of SGN loss and identify novel treatment strategies for successful cochlear implantation and help in identification of individuals who are at greater risk of hearing loss.